INITIATION OF HORMONAL THERAPIES IN CHILDREN

The purpose of this study is to evaluate the long-term effects of hormonal therapy on linear growth body composition and body fat distribution in children and adolescents. We expect that testosterone therapy will lead to the accrual of lean mass. To date we have noted remarkable changes in lean body mass and our future plans are to fill out patient number to achieve statistical significance.